LIVER TRANSPLANT REJECTION BY GLUCAGON VASCULAR ENHANCEMENT

This protocol tests the hypothesis that measurement of portal blood flow by doppler ultrasound prior to and after the administration of I.V. glucagon might provide a better method of detecting rejection in an early state. This study is conducted entirely in the Radiology Department and the GCRC Core Lab is required for the glucagon determinations.